Roles of peroxisomal dysfunction in alcohol-related liver disease

PROJECT SUMMARY / ABSTRACT
Alcohol-related liver disease (ALD) has been among the leading causes of morbidity and mortality worldwide.
However, the pathogenetic mechanisms in ALD are not well understood and, as such, there is an absence of
proven therapies. Emerging evidence now suggests that bile acid abnormalities play a causative role in the
pathogenesis of ALD. Peroxisomes are dynamic organelles controlling cellular metabolic processes, including
bile acid synthesis. Although early studies have implicated peroxisomal damage upon alcohol exposure, the
significance of peroxisomes in ALD is still being underestimated, leaving knowledge about the molecular
mechanisms of peroxisomal perturbation and its metabolic consequence, such as bile acid disorder, upon
alcohol intoxication remain rudimentary. Thus, the objective of this application is to overcome this knowledge
gap by determining the link between peroxisomal dysfunction, the consequent bile acid disorder, and the
development of ALD. Our preliminary studies suggest that alcohol exposure decreases hepatic peroxisomal
biogenesis in a manner dependent on a key peroxin, PEX3, in both alcohol-fed mice and patients with alcoholic
hepatitis. Using a unique mouse model of hepatocyte-specific peroxisome deficiency (PEX3 knockout), we found
that peroxisomes are critical for bile acid synthesis and that PEX3 reduction causes systemic accumulation of
toxic bile acid intermediates and increased susceptibility to alcohol. By pursuing the molecular mechanism
through which peroxisomal dysfunction causes liver damage, we found that peroxisome affects mitochondrial
and ER dynamics, at least partially, through bile acid intermediates. Moreover, we found a strong induction of
lipocalin 2 in ALD patients and mice as well as in PEX3 knockout mice. Further knockout of LCN2 in PEX3
knockout mice ameliorates PEX3 deficiency-induced liver injury. These data led us to hypothesize that alcohol
exposure induces peroxisomal dysfunction and the accumulation of toxic bile acid intermediates via targeting
PEX3, which in turn, promotes the development of ALD. We propose three Specific Aims to test the hypotheses.
Studies in Aim 1 will determine the role of hepatocyte PEX3 reduction in the pathogenesis of ALD using PEX3
knockout and alcohol intoxication mouse models; Aim 2 will characterize the toxicity of bile acid intermediates in
the development of ALD at the gut-liver axis; Aim 3 will explore the role of hepatocyte LCN2 in peroxisomal
dysfunction-induced liver damage in ALD. Knowledge obtained from the study will refine the importance of
functional peroxisomes in maintaining bile acid homeostasis to combat against toxic stimuli, such as alcohol.
The project is expected to have an important impact by defining new molecular targets for the prevention and/or
treatment of ALD and its complications.

Public health relevance
PROJECT NARRATIVE Alcohol-related liver disease is a leading cause of morbidity and mortality worldwide with limited effective therapies. This project is to investigate the roles and mechanisms of alcohol-induced peroxisomal dysfunction in bile acid synthesis disorder and the pathogenesis of organ damages. The goal of this project is to explore novel molecular targets for therapeutic interventions.